Core A: Administrative

SUMMARY – CORE A (Administration Core)
The "mRNA Vaccines for C. difficile Suppression” program (mVACS) consists of a highly interactive team of
investigators who are seeking to develop an mRNA vaccine platform to provide protection against
Clostridioides difficile-associated infection and disease. Project 1 is the engine for generating and testing
modified mRNA vaccines (Project 1 – Vaccine Development). This effort is accelerated and guided by
projects exploring strain diversity and microbial ecology (Project 2 – Antigen Discovery) and the mucosal
adaptive immune response to natural infection (Project 3 – Immunology). Supporting these three projects are
two scientific cores that will provide expertise, technical skills, and analysis of large deep-sequencing datasets
(Core B - Genomics Core), and collect samples for a patient cohort (Core C - Clinical Core). Core A
(Administrative Core) is the logistical and organizational component of the program that will handle regular
inter-project communication and ensure seamless exchange of data and information. Core A (Administrative
Core) is co-led by the mVACS program directors Dr. Bushman and Dr. Weissman. Their primary objectives will
be to monitor the scientific progress of the program, oversee distribution of resources, stimulate project
interactions and data integration, ensure compliance with NIH guidelines, and promote the scientific career
development of the mVACS team.